UC Irvine MODEL-AD

ABSTRACT
The goal of the University of California, Irvine MODEL-AD U54 Center is to develop novel mouse models of late-
onset Alzheimer’s disease (LOAD), to deeply phenotype these and to make all data and mouse strains available
to enable researchers to select the optimal mouse model and timepoints for therapeutic and intervention testing,
as well as testing of hypotheses concerning mechanisms of LOAD. During the past five years, we have generated
and deeply phenotyped mice with one component of our base genetic platform in which the Aß region of the App
gene was converted from the rodent to the human sequence, and we have recently introduced the second
component, a humanized MAPT (TAU) locus produced via gene-replacement. We have also used CRISPR and
genome replacement to model and validate nine GWAS identified LOAD risk loci and have characterized mice
with each of these both on a wild-type and 5xFAD background to determine their effects on plaque generation
and damage exerted on the brain in response to pathology. In this continuation, we will use the results of these
analyses to identify the combinations of LOAD risk variants most likely to phenocopy LOAD and introduce them
on two complementary hAb-KI, hTAU, hAPOE4 platform lines, designed to mimic sub-types of AD that have
been recently defined. To ensure translationability, we have an expanded focus on biomarkers and alignment
with human phenotypes. To that end we have established a new Core – the Neuroimaging and neurovascular
core (NIVC), which will provide brain imaging modalities currently employed in human AD subjects to align
phenotypes in our mice with human disease progression. We have also expanded our fluid biomarker analysis
efforts to include CSF, as well as plasma lipidomics and metabolomics to be compared to human AD plasma
signatures. Similarly, our bioinformatics and data management efforts have been expanded to include single cell
and nucleus RNA-seq and ATAC-seq, as well as spatial transcriptomics to enable alignment of data from our
models with human AD signatures, but also to understand the mechanisms underlying disease progression in
our mice. We are utilizing a comprehensive approach to evaluate our mice across their lifespans, which includes
behavioral/cognitive assessment, electrophysiological analysis, super-resolution synaptic imaging,
neuroimaging, bulk and single-cell RNA-seq, single cell level spatial transcriptomic analysis, unbiased
proteomics, and microbiome and metabolome investigations. The UCI MODEL-AD Center will leverage the
resources of our NIA-funded Alzheimer’s Disease Research Center combined with AMP-AD and other human
AD datasets to facilitate comparisons to the human condition to identify the best mouse models to evaluate
further. All data and models will be made available without restrictions, via The Jackson Labs, and data will be
explorable via the modeladexplorer.org website, and raw data freely available for download via the AD
Knowledge Portal.

Public health relevance
PROJECT NARRATIVE Understanding the complexity of the development of Alzheimer’s disease (AD) and developing and testing effective therapeutics and interventions requires the generation of animal models that faithfully recapitulate the disease. We have spent five years creating the individual components that we will now combine to produce mice that develop relevant aspects of AD. Furthermore, we will carry out deep phenotyping of these mice across their lifespans and align their pathologies and gene expression profiles with human signatures. All mice and data will be made freely available to all investigators, in academia and industry alike, so that the global research field can use these resources to develop and test therapeutics and ultimately combat AD.